MAPK-driven kinetochore stress in cancer

SUMMARY
Kinetochores (KTs) are large protein structures assembled upon centromeres during mitosis that bind to
microtubules (MTs) of the mitotic spindle to orchestrate and power chromosome movements. We have recently
discovered that a high proportion of human glioblastoma isolates suffer from a lethal form of KT stress, which is
triggered by oncogenic mitogen-activated protein kinase signaling [Mapk stressed KTs (MaSKs)]. MaSKs arise
when the Ras-Raf-MEK-ERK cascade is inappropriately active in mitosis, resulting in hyperstimulation of a
network of KT kinases that, in turn, hyperphosphorylate KTs, decreasing their MT binding capacity and causing
excessive KT-MT turnover.
The purpose of this grant is to reveal mechanistic details of our MaSK model while revealing MaSK relevance to
KT and cancer biology. Our overarching hypothesis is that oncogenic RTK-Ras-Raf-MEK-ERK signaling alters
the activity of key proteins involved in KT regulation causing cancer-specific destabilization of KT-MT
attachments and requirement for MaSK-associated compensatory mechanisms. Aim 1 will investigate the
nature, function, and regulation of MaSKs in glioblastoma isolates. Aim 2 will reveal the occurrence of MaSKs in
patient tumors. Aim 3 will elucidate MaSK-induced vulnerabilities in cancer and transformed cells.
MaSKs are highly relevant to cancer research. Our MaSK model provides a direct mechanism for chromosome
instability induced by oncogenic Ras pathway signaling, which is a key knowledge gap. Moreover, we have only
found MaSKs in cancer or transformed cells, where they trigger novel genetic and molecular dependencies not
observed in normal cells. MaSK-containing cells differentially rely on two non-essential domains of the mitotic
protein BubR1/BUB1B to facilitate recruitment of PP2A phosphatase to KTs to counteract MaSK-induced KT-
MT instability. Further, MaSKs themselves can serve as biomarkers for tumors and can be leveraged to discover
new MaSK-targeted therapies and to define a patient responder class.

Public health relevance
NARRATIVE Defects in cell division leading to the incorrect segregation of genetic material are hallmarks of all human cancers, but how these defects drive cancer initiation and progression remain poorly understood. The experiments described in this proposal are directly relevant to public health because they will provide new insight into the underlying mechanisms of tumor initiation and maintenance. Furthermore, these experiments will test the feasibility of targeting specific protein-protein interactions for the development of novel anti-cancer therapies tailored to late-stage, incurable cancers.